RIFAPENTINE AND INH COMPARED TO TWICE WEEKLY RIFAMPIN AND INH

To compare, at the completion of the followup phase, the clinical and bacteriological relapse rates associated with two study regimens for pulmonary tuberculosis.